Administration Core

The Administrative Core is responsible for allocation, management, and oversight of DRC resources. The
Administrative Core, in coordination with the DRC Executive Committee and the two Advisory Committees
(Internal and External) establishes and implements program objectives and Core utilization targets, reviews
and approves membership applications, organizes the research base into coherent interest groups and
facilitates communication among them, oversees program enrichment activities, and administers the Pilot &
Feasibility (PF) and Enrichment Programs. The Core is responsible for allocation of resources among different
Cores based on workflows, user base, technical, and strategic considerations. It is also responsible for
administrative oversight of personnel actions, financial management and reporting, conforming to university
standards for space and resource utilization, supporting best practices for rigor and reproducibility in research,
and providing appropriate human resource management to Core Directors to implement billing and expedite
technical support and personnel actions. The Core is also responsible for development, maintenance, and
timely update of the DRC website. The Core ensures continuity of operations in the event of replacement of
Core leadership or technical personnel, and oversees compliance with university regulations regarding human
subjects, animal experimentation, technology transfer, hazardous and radioactive material compliance. The
Administrative Core leadership represents the DRC within the faculty of the Vagelos College of Physician &
Surgeons and is responsible to ensure that the DRC figures prominently in the school’s strategic and
programmatic goals. Dr. Domenico Accili, MD will serve as Director of the Administrative Core. In this capacity,
he will oversee DRC activities, including DRC membership, administration of Core Facilities and PF program,
convene the Advisory Boards and attend yearly meetings of the DRC PIs. He will be assisted by Dr. Rudolph
Leibel, DRC Co-PI, and Director for the Pilot & Feasibility Program. Together, the Co-PIs will integrate DRC
activities with institutional Centers and initiatives that can benefit diabetes research and training. They will
ensure the seamless operation of DRC Core facilities and their integration with university-wide facilities
(including the NY Obesity Research Center) to avoid duplication of costs and effort. In a similar vein, the Co-
PIs will proactively integrate DRC activities with those of other DRCs, especially the neighboring Northeast
Centers, as well as other NIDDK program activities. The Administrative Core is also responsible for oversight
of the Enrichment Program